VISION CONTROL MECHANISMS

It has been shown that cyclic nucleotides (cGMP, cAMP) mediate many of the normal functions of the neural retina, especially as related to the visual process. Moreover, protein kinases (cAMP- dependent protein kinase, C-kinase) mediate the function of these nucleotides as well as transduce other important signals (eg, calcium, lipids, etc.). We have evidence that (1) abnormalities in cAMP-dependent protein kinase may be involved in human retinoblastoma, (2) cyclic GMP accumulation and distribution is abnormal in photoreceptor cells of an animal model of inherited retinal degeneration and (3) C-kinase could be involved in normal light/dark mechanisms in the photoreceptor outer segment.